Call Me Doctor ESTEEMED Scholars Program at Clemson University

ABSTRACT/SUMMARY
To address the shortage of underrepresented STEM professionals, The Call Me Doctor® ESTEEMED Scholars
Program will serve as the undergrad arm of Clemson’s existing Call Me Doctor® Graduate Fellowship Program,
establishing a pipeline for underrepresented undergraduates in bioengineering and bioengineering-related fields.
The program integrates sustainable strategies through a combination of existing and innovative programming to
offer academic, mentoring, and research support to increase participation of underrepresented students in PhD
and MD/PhD careers in biomedical research. The program objectives will be achieved through the following
aims: AIM 1 - Create communities of support through formal and informal mentoring networks, AIM 2 - Support
early development of research skills and scientific communication, and AIM 3 - Facilitate exploration of advanced
careers related to biomedical engineering through professional and career development workshops with
subsequent self-reflection to create a Program Portfolio. The key elements of the Call Me Doctor® ESTEEMED
Scholars Program are 1) EUREKA!, a Summer Bridge program that provides early immersion in research
experiences for incoming freshmen that will be combined with coursework in computing and introductory
biomedical science concepts, 2) Academic year activities including laboratory rotations for lab selection;
laboratory research; mentoring by Call Me Doctor® graduate fellows, peers, faculty, and staff; lunch-and-learn
career panels; visits to biomedical and clinical research labs, and presentation of research at the annual Call Me
Doctor® Symposium; 3) Development of a program portfolio including self-reflections of research and career
exposures; 4) Sophomore summer research experience; and 5) Junior year transition to the bioengineering
department’s advanced thesis-based honors program, a program with an over 75% success rate of enrollment
in advanced degree programs. The diverse team of five Clemson University investigators is led by an African-
American female (Alexander-Bryant), recipient of a 2021 NSF Early CAREER Award, and an African-American
male (Gilmore), director of the existing Call Me Doctor® Graduate Fellowship Program. All team members are
members of the bioengineering department’s Diversity and Inclusion Committee, which the PI directs. Outcomes
of the program include 1) development of research and scientific communication skills, 2) presentation of
research at local and national conferences, 3) publication of research in scientific journals, 4) participation in
sophomore summer research, 5) transition upon junior year into the bioengineering department’s honors
program, and 6) 75% matriculation into graduate school.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The proposed research is relevant to public health because it aims to increase participation in advanced biomedical research careers among students historically underrepresented in STEM. Providing opportunities for early biomedical research training to students from diverse backgrounds will benefit the U.S. by increasing preparedness to meet the nation’s biomedical research needs and supporting innovation in healthcare technology inclusive of the nation’s diverse pool of potential scientists.